SHARE Administrative Core

To address research gaps in alcohol and HIV comorbidity in young people living with HIV (YPLWH), particularly in Florida, Florida State University’s SHARE Program (Self-management of HIV and Alcohol Reaching Emerging adults) will synergize senior and emerging faculty across the state, national experts, youth stakeholders and community partners to address the priorities in RFA-20-009. The proposed Administrative Core (AC) will draw on a multidisciplinary team of experienced senior researchers, community representatives, and administrators to set, implement, and evaluate the Program Project’s scientific agenda and ensure efficient administrative and fiscal coordination of our scientific research and capacity-building initiatives. This AC will be the hub for program activities and coordination across the projects and resource cores and the over-arching liaison between the SHARE program and internal and external affiliated entities that collaborate on and monitor our work. Through the AC, SHARE leadership will maintain our focus on community-engaged innovations in translational behavioral science to improve HIV and alcohol outcomes in young people (ages 18-29) who are a population with high rates of HIV and alcohol abuse. We will do this in the state of Florida, which has the highest rate of new HIV infections in the US. AC mechanisms are designed to maximize synergy across the SHARE program and provide a foundation for future research. The AC will create an environment in which research on comorbid HIV and alcohol use thrives and in which the SHARE program serves as a catalyst to scientific, practice, policy, and youth stakeholder communities at the forefront of the HIV/AIDS epidemic in a state-wide initiative within a state hardest hit by the HIV epidemic.